Administrative Core

Project Summary/Abstract – Administrative Core
The Administrative Core is the organizational underpinning for the proposed studies. These are organized into
five projects across four sites and four resource cores. The studies make use of an integrated approach toward
the chief scientific goal of understanding the neuronal basis underlying coordinated orofacial behavior: thus the
lead investigators have a wide range of expertise from genetic manipulation of viruses for brain connectivity
studies and development of new tracing probes, in vivo electrophysiology to allow neuronal recording in awake
behaving animals, in vivo optical imaging with adaptive optics to computer science automated image
recognition routines (Projects 1 to 5). The three Resource Cores provide expertise and service for data
analysis and data sharing, expertise for high precision histology and anatomy, including raw images for the
shared portal of primary data in the data science core, and dissemination of adaptive optics-based two photon
microscopy.
The Administrative Core oversees tracking of all funding of personnel linked to projects and/or cores for these
studies. Funding will be administered by a main contract to UCSD and subcontracts to Allen Institute, Ben
Gurion, Boston U, Johns Hopkins, and MIT. The Administrative Core will also manager funds for our
Postbaccalaureate Summer Research Program, a ten-week program is designed to help two underrepresented
minorities achieve additional experience for PhD programs.
The management of the budget will be the purview of a fund manager hired through UCSD Department of
Physics. The scientific governance will be accomplished through regular meetings held on Zoom of an internal
advisory committee that will include members from each project and resource core. Professor and Chair Jing
Wang has agreed to serve as an independent ombudsman to help resolve scientific conflicts in consultation
with an external scientific advisory committee, which remains to be appointed.